Planning and Evaluation

The Cancer Center Senior Leadership Group (CCSLG) and the CCSG Execufive Committee manage Program planning and evaluation as a continuous and deliberate process. External consultants help the Cancer Center identify best practices at other insfitufions that could be of benefit to the University of Virginia (UVA) Cancer Center. In parallel, the Cancer Center relies on internal monitoring and feedback to determine how to best implement these pracfices to advance its goals. This external-internal dynamic ensures a planning and evaluation process that generates Program changes, strengthens clinical research leadership and infrastructure, provides new and improved Shared Resources, encourages collaborations, and implements recruitments. Specifics of these efforts are described throughout this application. Funds requested in this renewal will cover the travel, honorarium, and per diem costs associated with external advice and consulfing. Such activities include visits by the External Advisory Committee and by ad hoc advisors, and seminars and symposia at which speakers serve as Cancer Center consultants.

Public health relevance
RELEVANCE (See Instructions): Planning - both strategic, for long-range issues, and tacfical, for implementafion issues - is essenfial for efficient utilization of resources and for programmafic success. The effectiveness of our plans and implementation is monitored through a variety of